Exploring Age Differences in Patient Reported Cognitive Function Trajectories among Hematopoietic Stem Cell Transplant and Chimeric Antigen Receptor T-cell patients and Linking Two Key Measures

ABSTRACT
Two established therapies to control and/or cure many hematologic diseases are hematopoietic cell
transplantation (HCT) and Chimeric antigen receptor t-cell (CAR-T) treatment. In the last few years, there are
increasing number of older patients receiving both treatments. Cognitive dysfunction, a common and serious
side effect of HCT and CAR-T, was associated with older age. Patient-reported outcomes (PROs), or patient
reports of their own symptoms and functioning without interpretation by anyone else, are critical to better
understand patients' symptom trajectories, yet very few studies assess PROs among CAR-T patients. Small
sample size and single-site studies are limited in their ability to understand potential age differences and even
less among racially or socioeconomically diverse older survivors, leading to urgency for PROs from larger
more representative data, such as a registry. The Center for International Blood and Marrow Transplant
Research (CIBMTR) is an NIH-funded research collaboration that maintains a clinical outcome registry for HCT
and CAR-T recipients and, beginning in 2016, developed a strategy and infrastructure for the routine collection
of PROs. Patient-Reported Outcomes Measurement Information System (PROMIS) measures were chosen for
their flexibility in sets of tools, rigorous testing, and translatability across other diseases and populations. Unlike
many other available PRO measures, PROMIS measures are assessed for differences in how items are
interpreted across different groups, such as by race/ethnicity and age, known as differential item functioning
(DIF). However, the PROMIS cognitive function measure has only been assessed for DIF in 8 of 32 items.
Previous research in HCT most often used a different measure to assess cognitive function: European
Organization for Research and Treatment of Cancer Quality of Life Questionnaire (EORTC). A psychometric
analysis known as linking has been used to develop crosswalk tables to directly compare PRO measures, like
PROMIS depression, but has yet to link PROMIS to EORTC. Using data on the U.S. general population from
an online panel, specific aim 1 will be the first study to use psychometric analysis to assess DIF for the full item
bank of PROMIS cognitive function measure by age, race/ethnicity, and income and produce a crosswalk table
to directly compare scores on the PROMIS and EORTC cognitive function measures. Using CIBMTR data,
specific aim 2 will use linear mixed modeling to assess cognitive function by age and explore potential
racial/ethnic and SES disparities among older patients. This project will produce: (1) recommendations for use
of cognitive function measures in CIBMTR registry; (2) a crosswalk table directly linking PROMIS and EORTC;
(3) a novel description of cognitive function trajectories of HCT and CAR-T patients by age; (4) explore
racial/ethnic and socioeconomic disparities in PROs among older HCT and CAR-T patients. This project will
provide preliminary data for an R01 proposal to assess disparities in survivorship experience using large
registry database and, if necessary, inform intervention development to mitigate such disparities.

Public health relevance
PROJECT NARRATIVE Older adults are increasingly being treated with Hematopoietic stem cell transplantation (HCT), with similar promise in chimeric antigen receptor T-cell (CAR-T) therapy, yet little is known about potential patient reported outcomes (PRO) differences for older patients, particularly cognitive function which has shown to impact older HCT patients significantly more compared to younger. The current research proposes to establish confidence in validity of measures assessing cognitive function, assess age differences in cognitive function after HCT and CAR-T, and explore trajectory patterns of cognitive function and other PROs by race/ethnicity and socioeconomic status in older HCT and CAR-T patients. The proposed research will produce evidence of construct validity for cognitive function measures used in a national HCT and CAR-T registry, link scores of two dominant measures of perceived cognitive function and provide novel description of HCT and CAR-T PRO trajectories.